Activation of T gamma/delta cells by Borrelia glycolipids

PROJECT SUMMARY/ABSTRACT
The immune response to Borrelia burgdorferi is complex and at times, enigmatic. Most of the studies that have
been done on the immunology of Lyme disease have focused on the role of the lipoproteins that are abundant
in the spirochetes. We have shown that B. burgdorferi has unique glycolipids (MGal) and cholesteryl glycolipids
(CGal) that have important biological and structural properties and include the ability to induce formation of
antibodies. Gamma-delta (γδ) T cells straddle innate and adaptive immunity and are well known for responding
to lipid antigens, but responsiveness has only rarely been demonstrated toward a specific bacterial lipid antigen.
Based on this information, we tested MGal and CGal for activity to stimulate a specialized γδ T cell capable of
long-lived memory formation and co-production of interferon gamma (IFNγ) and IL-17A, cytokines important for
anti-pathogen immunity. Surprisingly, MGal was nearly as efficient as live Borrelia in the induction of IFNγ and
IL-17A from these nonconventional T cells. These findings led to this proposal whereby we will evaluate the the
capacity for MGal and CGal preparations to activate distinct γδ T cell subsets that contribute to anti-pathogen
immunity. The function of the γδ T cells will be evaluated using unbiased and large scale cytokine high throughput
assays in vitro and in mice, and thereafter, we plan a mechanistic approach to evaluate how these Borrelia lipids
elicit γδ T cell functional responses. Given the complexity of the immune response in Lyme disease, this proposal
will explore the role of diverse γδ T cell subsets in the response to B. burgdorferi infection. The manner of lipid-
elicited γδ T cell function will be determined, and the corresponding functional response of the γδ T cells will be
evaluated mechanistically. We anticipate that the γδ T cell-Borrelia axis will be an important contributor to the
immune response during Lyme disease.

Public health relevance
PROJECT NARRATIVE Borrelia burgdorferi, the etiologic agent of Lyme disease, has unique glycolipids that are biologically and antigenically important. We will test the ability of these lipids to activate γδ T cells to produce cytokines. These cells are uniquely known for responding to lipids, so we expect that this will be an important pathway of the immune response in Lyme disease.